Mechanisms and Ex Vivo Repair of Cold-Storage Injury in Human Kidney Allografts

PROJECT SUMMARY
The average duration of cold-storage for deceased-donor kidneys in the U.S. can range from ~9 to >30 hrs in
the U.S. depending on geographic location. It is well established that the longer a kidney is stored cold prior to
transplant, the greater the likelihood of post-transplant complications like delayed graft function. This is
particularly true for organs from aging donors or donors with co-morbidities—an ever-expanding proportion of
the U.S. donor pool—which display increased sensitivity to injury during cold storage. Little is known about the
mechanisms that determine the rate and extent of cold-storage injury in human organs. This lack of knowledge
presents a critical barrier to the development of therapeutic strategies to reduce the clinical impact of cold-storage
injury. We have recently discovered that cold storage induces human kidneys to produce fibrinogen within renal
tubular cells. Upon restoration of normothermia/normoxia, fibrinogen is secreted into the vasculature where it
can aggregate erythrocytes in a rouleaux formation leading to pathologic plugging of microvessels. We
hypothesize that renal fibrinogen is a major effector of cold-storage injury and therefore represents a viable target
to improve organ resilience after cold storage. Ex Vivo Organ Perfusion (EVOP) has emerged as a research and
clinical platform providing an opportunity to directly test this hypothesis in a translationally relevant setting. Here,
we will exclusively use human tissues to achieve two objectives: 1) Determine the mechanism by which cold-
storage induces renal fibrinogen synthesis; and 2) Evaluate EVOP as a therapeutic platform to ameliorate
fibrinogen-mediated pathology pre-transplant. Successful completion of these objectives will establish a new
paradigm for prevention of cold-storage-induced organ injury with the potential to save patient lives by improving
both access to organs and post-transplant outcomes.

Public health relevance
PROJECT NARRATIVE We have recently discovered that human deceased-donor kidney allografts produce fibrinogen in response to cold-storage, which can cause pathologic plugging of microvasculature upon reperfusion via local aggregation of red-blood cells (rouleaux formation). In this grant, we will: 1) Define the mechanisms that drive this fibrinogen stress response during cold-storage; and 2) Develop pre-transplant therapeutic strategies to ameliorate this pathology during ex vivo organ perfusion. All work will be performed using a well-established pipeline for human tissues (transplant-declined human organs and clinical biopsy specimens) to ensure that successful completion of our aims will translate rapidly into reduced mortality for kidney-transplant patients.